THE COST PLUS FIXED FEE (CPFF) TO TO REFURBISH AND IMPROVE NCI FREDERICK INFRASTRUCTURE WILL HAVE A BASE AND THREE (3) OPTIONS.

The Advanced Technology Research Facility (ATRF) was completed in 2013.
The existing ATRF Data Center is running out of rack space for additional
required compute and storage resources. The existing space is approximately
50% built out. This scope of work is to build out the remaining 50% of the
Data Center with required racks, power, and HVAC. The remaining build out
will be two phases. Phase one will include twenty-six racks (21 new racks
plus five new racks replacing existing network racks) with rear air
containment plenum, eleven cooling units, power, and HVAC. Phase two will
include twenty racks, eight cooling units with a hot aisle enclosure system.
This Task Order will be for Phase one only.